The Role of KCa3.1 in Microglial function and in Parkinsons disease pathogenesis

Abstract
Recent studies have begun to uncover the central role of microglia-mediated neuroinflammation in Parkinson’s
disease (PD) pathogenesis. Increasing evidence suggests that microglia-driven innate immunity could further
potentiate deleterious α-synuclein (αSyn) aggregation and progressive neurodegeneration. However, we lack an
in-depth understanding of the cellular mechanisms regulating αSyn-induced innate immunity. Therefore,
identifying signaling mechanisms that regulate microglial function in response to Parkinsonian pathology may
lead to the development of novel immunomodulatory therapies for PD. We recently discovered that the transcript
and protein expression levels of the calcium-activated potassium channel KCa3.1, best known for its role in
immune cell calcium signaling, are elevated in activated microglia in both postmortem PD brains and in preclinical
models of PD. We further identified that disruption of either FYN or STAT1 dampens reactive microglia activation
responses via modulation of inflammatory mediators in aggregated αSyn (αSynagg)-stimulated primary microglia.
Importantly, the highly selective and orally active KCa3.1 inhibitor Senicapoc reduced neuroinflammation and
nigral dopamin(DA)ergic neurotoxicity in a preclinical mouse model of PD, suggesting that KCa3.1 plays a
multifaceted role by governing disease pathology. Despite these encouraging findings, the exact cellular
mechanisms by which KCa3.1 regulates microglial function in the context of synucleinopathy remain poorly
characterized. Herein, we propose three integrated aims to test the central hypothesis that KCa3.1 promotes
αSynagg-mediated progressive nigral DAergic neurodegenerative processes via activation of the microglial Fyn-
STAT1 signaling axis and that the in vivo inhibition of KCa3.1 restores microglial homeostasis and affords
DAergic neuroprotection in the context of synucleinopathy. In Aim-1, we will test the hypothesis that upregulation
of KCa3.1 induces the proinflammatory microglial activation phenotype and nigral DAergic neuronal loss in the
context of synucleinopathy. In Aim-2, we will test the hypothesis that the Fyn-STAT1 signaling axis drives
microglial responses to PD-like pathology in a KCa3.1-dependent manner. In Aim-3, we will test the hypothesis
that inhibiting KCa3.1 activation is efficacious in reducing reactive microglial activation and progressive PD-like
disease pathology. The proposed studies are innovative, utilizing a combination of transcriptomic profiling, RNA
in situ hybridization (ISH), imaging analysis, the RT QuIC assay for αSynagg seeding, CRISPR/Cas9 KCNN4
knockout (KO) mice, transgenic conditional KO mouse models, and electrophysiological recordings to test how
microglial KCa3.1 influences progressive neurodegenerative processes in PD. These studies address key
mechanistic aspects regarding the functional roles of KCa3.1 in PD pathogenesis and may aid in the identification
of new molecular determinants that can be targeted for slowing or halting PD progression and/or repurposing
Senicapoc for PD therapy.
1

Public health relevance
Narratives This proposed project is directly relevant to Parkinson’s disease (PD) given that the discovery of KCa3.1’s mechanistic role in experimental models of Parkinson’s disease (PD) is anticipated to aid in the identification of novel therapeutic strategies for PD. KCa3.1 is considered to be a relevant target because of a positive association between microglia-mediated neuroinflammation and neurodegeneration. Most importantly, the proposed research is relevant to the missions of NIH and NINDS because it paves the way for clinical trials with Senicapoc, a brain penetrant KCa3.1 blocker, in PD patients to halt or slow the progression of neurodegenerative processes, thereby easing PD’s socioeconomic burden on patients and society. 2